Chronic GVHD and Management of its Sequelae

PROJECT SUMMARY
We propose to organize and conduct the Tenth (10th) Annual Pediatric Transplant and Cellular Therapy
Consortium (PTCTC) Meeting at the Fort Worth Convention Center in Fort Worth, TX, on May 09, 2023. A unique
aspect of the Annual PTCTC Educational Meeting is that it is jointly held with the international American Society
of Pediatric Hematology Oncology Conference (May 10–13, 2023) and includes a Combined Plenary Session,
bringing pediatric hematology oncology professionals together from around the world. Allogeneic hematopoietic
cell transplantation (HCT) is a potentially curative therapy for childhood hematological conditions. Advances in
basic, translational, and clinical research have significantly increased the number of long-term survivors. The
remarkable success is owed in part to the presentation, dissemination, and sharing of new knowledge at annual
meetings. However, none is solely dedicated to pediatric HCT. A significant problem in the field is chronic graft-
versus-host disease (cGVHD). Despite cure, cGVHD is the leading cause of late morbidity and mortality. With
their longer life expectancy, a critical need exists to understand the etiology, prevention, development, and
diagnosis, and systematically evaluate and monitor cGVHD in children. The 10th Annual PTCTC Educational
Meeting will convene clinicians and scientists who will present on the immunologic mechanisms leading to the
initiation and development of cGVHD. This will provide a platform that stimulates how to implement systematic
cGVHD assessments in a busy clinical setting. In doing so, innovative clinical strategies can be developed and
tested across multi-site collaborations and networks, including novel therapeutics for pediatric-specific cGVHD
clinical trials. This 1-day program will invigorate the field of pediatric HCT. The primary objectives include I)
identify optimal donor selection strategies that can be standardized and implemented irrespective of the treating
institution; II) systematically conduct comprehensive cGVHD assessments that accurately classify individual
organ and global organ severity at baseline and in follow-up irrespective of the evaluator; III) to review the ‘state
of the science’ in cGVHD immunology and management of affected organ dysfunctions (e.g., pulmonary, ocular,
vaginal); IV) to enhance the understanding of wellness, thereby maximizing long-term quality-of-life and
survivorship of pediatric HCT patients; and V) to promote networking and collaboration of research and clinical24
trials involving pediatric HCT patients. The results of the 10th Annual PTCTC Educational Meeting will likely
enhance our understanding of the basic, translational, and clinical state of the scientific research in pediatric-
specific cGVHD, which will provide an opportunity and platform to engage young and senior clinicians and
scientists to develop collaborative research. The Organizing Committee will make every effort to enhance
diversity by increasing individuals from diverse backgrounds, including those from underrepresented groups.
Participation of trainees and underrepresented minorities is especially encouraged through travel awards.

Public health relevance
NARRATIVE This Tenth (10th) Annual Pediatric Transplant and Cellular Therapy Consortium (PTCTC) Educational Meeting on Chronic Graft-versus-Host Disease (cGVHD) and Management of its Sequelae will be attended by interdisciplinary clinicians and scientists, including minorities and underrepresented groups. The educational program will facilitate new knowledge in this field, promote collaborative research, and enhance the maturation of young investigators in pediatric hematopoietic cell transplantation. Further, this conference will bridge the clinical and scientific gap between pediatric and medical HCT specialists treating children, adolescents, and young adults with cGVHD.